FOOD HYPERSENSITIVITY IN THE PATHOGENESIS OF ATOPIC DISORDERS

The purpose of this study is to study the nature of cells in immediate and late phase reactions to oral food challenges and look for presence of delayed- onset reactions to foods. Hypotheses: 1. Mediators released in the serum will reflect activation of mast cells and eosinophils after, respectively, immediate and late phase reactions to oral food challenge. 2. In a negative immediate challenge, symptom scores will show no difference between placebo and active weeks during prolonged double-blind feeding of suspected foods.